Community Engagement Core

Our CEC objective is to facilitate and enhance collaborations that are responsive to
community needs, with the overarching vision and aim of improving community health and
public health practice for urban and rural communities. Our stakeholders include urban and rural
communities, policy-makers, environmental resource managers, and public health
professionals. Key partnerships with community-based organizations, tribes, and educators
ground and guide our areas of focus. We are a robust team with diverse skill sets in research
translation and community engagement. In 2019, with new staff and incoming co-director, we
engaged in critical reflection about the effectiveness of our strategies to-date and the strength of
our historic partnerships. We continue to focus on air quality and inhalation-based exposures,
as low-income communities in south Seattle experience disproportionate diesel exposures and
eastern Washington communities face persistent wildfire smoke. Our environmental health
programs with teachers carry our related work on inhalation exposures focus further with
lessons on the health impacts of vaping. We are poised to deepen and extend our work through
impactful projects, research translation and impact assessment, including through our enhanced
focus on disaster research response (DR2). Over the next five years, we will grow our DR2
areas of work, fostering our community of practice and providing local, statewide, and national
leadership. In addition to ongoing excellence in science communication and research
translation, our CEC will also formalize a Community Responsive Research Lab. With the
development of this resource, we will enhance our ability to connect communities with
researchers who can support community-driven projects. Throughout, we leverage our expertise
and EDGE strengths to enhance environmental health literacy and promote environmental
public health.